CHEETAH Center for the Structural Biology of HIV Infection, Restriction, and Viral Dynamics

CORE SUMMARY
This Core is designed to provide CHEETAH Center members with access to novel approaches for imaging and measuring
the behaviors of different HIV-host systems under investigation in our Center. Specifically, our Tools for Structural and
Mechanistic Studies Core (Core 2), will develop new methodology and provide CHEETAH Center members with access to
state-of-the-art instrumentation and expertise in Fluorescence Spectroscopy and Dynamics, Scaffolds for Structure
Determination, and Electron Cryotomography.
Component 1 (Fluorescence Spectroscopy and Dynamics) will provide instrumentation and expertise in fluorescence
labeling and single-molecule fluorescence approaches to studies of biological structure and dynamics. Novel methods for
correlating biological processes in real time and for linking cryoEM structural studies to dynamic analyses are also being
developed.
Component 2 (Scaffolds for Structure Determination) will generate and provide antibody-like molecules called “Synthetic
Antigen Binders” (sABs) as fiducial markers for cryoEM structure determinations. The Component will also optimize and
apply new, empowering classes of “universal” molecular fiducials based on: 1) transportable binding epitopes, or 2)
secondary antibodies. Universal fiducials for more challenging RNAs and RNA-protein complexes are also being created.
Component 3 (Electron Cryotomography) will incorporate the powerful and rapidly advancing technologies of correlative
light and electron microscopy (CLEM), focused ion beam (FIB) milling, and electron cryotomography (ECT) to reconstruct
native molecular landscapes at unprecedented resolution. The Component will also develop new functional correlative
reporters that can be located by fluorescence or by electron energy-loss spectroscopy (EELS) imaging, and apply these
reporters to problems in HIV-1 sub-viral organization, virus entry, and viral core replication and trafficking.

Public health relevance
CORE NARRATIVE This Core will enable CHEETAH investigators to visualize and follow the behavior of HIV-related complexes by using fluorescence spectroscopy to analyze structure and dynamics, antibody technology to facilitate 3D structure determinations, and electron cryotomography to visualize complexes in their native cellular environments.